Dissecting the Signaling and Cellular Mechanisms of Notochord Patterning In Zebrafish

ABSTRACT
The vertebral column or spine is a segmented support structure composed of alternating vertebrae and
intervertebral domains. In zebrafish, the notochord sheath segments into cartilage-like (col9a2+) and
mineralizing (entpd5a+) domains in a Notch dependent process. Osteoblasts are then specifically recruited to
the mineralized domains, producing highly regular and symmetrical vertebrae. Notochord segmentation occurs
sequentially along the anterior-posterior (AP) axis, much like somite formation, which takes place alongside the
notochord several days earlier in development. However, unlike somitogenesis, notochord segmentation is not
associated with oscillations in Notch signaling, suggesting that different signaling mechanisms control notochord
and somite segmentation. The goal of this proposal is to integrate genetics, cell biology, and quantitative imaging
methods to investigate the signaling processes that drive notochord segmentation. Specifically, we will elucidate
both the clock mechanism that times the addition of new mineralizing segments at a rate of about 2-3 segments
per day and the mechanisms that ensure that segments form in the correct spatial location. Finally, we will
investigate how after segments are formed their boundaries are sharpened via self-organizing cellular and
mechanical interactions. The mechanisms elucidated by our studies will build a new paradigm of periodic pattern
formation. Our studies will also help understand the formation and organization of gene expression domains
within biological tubes, which may underlie the regionalization and specialization of functional domains within
organs.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed studies will investigate mechanisms controlling notochord segmentation in zebrafish that are relevant for understanding the formation of distinct domains in epithelial organs.